The Green Housing Study: New Orleans

DESCRIPTION (provided by applicant): Project Summary: The Green Housing Project (New Orleans) The Green Housing Study is a 12-month prospective cohort study, examining how green building practices affect indoor air quality and the health of asthmatic children ages 7-12 who live in HUD-subsidized (public housing and/or low-income) housing in New Orleans. This project is part of the Centers for Disease Control and Prevention's Green Housing Study, a multi-city study evaluating housing factors that are energy efficient and have the potential to mitigate the negative health outcomes of low income children with asthma.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative: The Green Housing Study (New Orleans) The Green Housing Study is a 12-month prospective study examining the impact of green housing practices on indoor environmental contaminant level and environmental health of low-income children with asthma. Eligible children will be recruited from HUD-subsidized housing in New Orleans, Louisiana.